Epithelial-intrinsic restriction of Cryptosporidium

ABSTRACT
Cryptosporidium infections are a leading cause of diarrheal associated death in children under the age
of five. There is no vaccine or universally effective treatment for Cryptosporidium, highlighting the need for
intensive study of the host immune response to infection. Cryptosporidium invades the host small intestine and
establishes an intracellular vacuole on the apical surface of intestinal epithelial cells. The epithelial cell serves
as both a parasite niche and a host sentinel, where the parasite is sensed by the host and immune pathways
are activated to control the infection. Despite decades of study, however, the pathways and effectors that promote
parasite restriction in the epithelial cell and their mechanisms of action remain elusive.
Intestinal epithelial cell death and autophagy are two conserved mechanisms of host defense against
enteric pathogens and recent evidence suggests that both might be important for cell-intrinsic control of
Cryptosporidium. Taking advantage of advances in intestinal epithelial organoid culture, I have shown that
organoid monolayers mutant for autophagy and cell death experience enhanced Cryptosporidium growth,
implicating both processes in epithelial-intrinsic parasite restriction. Based on these preliminary findings and our
knowledge of autophagy and cell death in defense against other enteric pathogens, I hypothesize that autophagy
mediates parasite restriction by degrading the parasite vacuole and that cell death limits parasite growth by
eliminating the parasite’s intracellular replicative niche. I will test these hypotheses using epithelial organoid
monolayers as a model in vitro system. I will characterize the pathways that trigger both autophagy and cell
death during Cryptosporidium infection and I will employ fluorescent transgenic parasites and
immunofluorescence microscopy to understand how these processes impinge upon parasite growth and survival.
Furthermore, I will use microscopy and flow cytometry to test whether Cryptosporidium can inhibit cell death in
organoids. These studies will be the first to identify and dissect the mechanisms employed by intestinal epithelial
cells to counteract Cryptosporidium intracellular survival and growth, lending crucial insights into host-pathogen
conflict, conserved mechanisms of host defense, and the regulation of immune pathways relevant not only to
Cryptosporidium but to other enteric pathogens and inflammatory diseases of the intestine.

Public health relevance
PROJECT NARRATIVE Diarrheal disease caused by the parasite Cryptosporidium imposes a significant burden on children and immunocompromised adults. Cryptosporidium invades and replicates within the epithelial cells of the host small intestine, however, the mechanisms by which the immune system mediates restriction of the pathogen in this niche remain a mystery. My studies will reveal the cell-intrinsic immune pathways and mechanisms employed by epithelial cells to counteract intracellular Cryptosporidium growth and control infection.